LIVE IMAGING OF BONE REGENERATION IN ZEBRAFISH

ABSTRACT Mammalian bone has the capacity throughout life to regenerate in response to fracture injury. However, there is a ceiling for this regenerative potential, with hurdles to regeneration after a major trauma like limb amputation. This has a significant socio-economic impact, as it is estimated that at least one in two Americans over age 50 is expected to have or be at risk of bone disease, and every year an estimated 1.5 million individuals suffer a fracture due to bone disease. We have developed imaging methods to study how osteoblasts drive bone regeneration in zebrafish, which display robust regeneration after major injury to bony structures like their fins, scales, and jaws. Our goal is to exploit this regenerative capacity, new imaging platforms we have created, and the molecular genetic approaches available in zebrafish to improve our ability to understand and manipulate the regenerative capacity of bone. We have recently identified Erk signaling waves as a mechanism for the control of osteoblast regeneration. This Supplement application extends our original proposal by testing the hypothesis that mechanical signals contribute to osteoblast regeneration by integrating inputs from the Erk pathway and Hippo/Yap-Taz pathway, another signaling pathway playing crucial roles in bone morphogenesis and regeneration.

Public health relevance
RELEVANCE STATEMENT Our experiments will reveal mechanisms by which osteoblast integrate mechanical and chemical cues to coordinate bone regeneration. They will also uncover similar mechanisms that allows the coordination of osteoblast and epidermal dynamics during bone regeneration.